IPREP: IUPUI Graduate Preparation for the Biomedical and Behavioral Sciences

IPREP Project Summary
The IUPUI Graduate Preparation for the Biomedical and Behavioral Sciences (IPREP) will combine academic
and professional enhancement with extensive research experiences to prepare talented college graduates
from diverse backgrounds for success in rigorous Ph.D. and M.D./Ph.D. programs in the biomedical and
behavioral sciences. Six students will be recruited annually from a pool of high-performing diverse populations
from existing IUPUI programs, historically black colleges, Hispanic serving institutions, tribal colleges, and
other universities nationwide. Scholars will begin the yearly program on June 1st with a one-week orientation
where their skills and needs will be assessed, and from which a detailed personal development plan will be
established. Weeks 2-8 the scholars participate in professional development activities, GRE training, research
training (CITI), mentor training, and end with a two-week rotation in three labs chosen by the Scholars. Every
Fellow will then be assigned to an experienced research-active mentor who will incorporate the Fellow as an
employee into their research enterprise. Scholars will receive additional ongoing support from the IUPUI
Graduate School, the IUPUI Graduate Mentoring Center, and the Office of Vice Chancellor for Research that
will include individualized advising, professional development, assistance with graduate school applications,
planning for graduate school visits and interviews, as well as monthly monitoring and reporting of progress to
the Program Director. IPREP Scholars will leave the program with enhanced laboratory and research skills,
including improved abilities to ask and solve research questions (critical thinking, rigor, and reproducibility),
increased understanding of expectations of graduate programs, awareness of process for seeking external
funding, improved self-confidence, and ability to succeed in a competitive academic environment. At least five
of the six IPREP Scholars will be successful in obtaining admission to rigorous Ph.D. and Ph.D./M.D. programs
and will complete their graduate/professional programs.

Public health relevance
Project Narrative The long-term goal of the IUPUI Postbaccalaureate Research Education Program (IPREP) is to improve diversity in the community of graduate students and faculty for six targeted Ph.D. programs in the biomedical and behavioral area at IUPUI. Training will be available for six students each year in areas of interest to the national health including Basic Medical Sciences, Clinical Psychology, Addictions Neuroscience, Human Performance, Medical Neuroscience, Biomedical Engineering, and multidisciplinary Artificial Intelligence, with the goal of matriculation into these graduate programs at IUPUI or similar graduate programs at other universities. This will be accomplished through laboratory research experiences and with supporting social academic, professional, and career development activities provided by IPREP.